Stress Granule Formation in the Antiretroviral-Mediated Dysregulation of Oligodendrocyte Maturation in HIV-HAND

PROJECT SUMMARY
HIV-Associated Neurocognitive Disorder (HAND) is experienced by about half of people living with HIV (PWH),
and presents as a spectrum of neurocognitive impairments. While the majority of PWH in the United States are
virally suppressed or undetectable, the overall proportion of PWH with HAND symptoms has remained
unchanged. One of the hallmarks of HAND is the atrophy of white matter, a pathology that persists in HAND
patients treated with ART. The duration of ART treatment in PWH has been shown to correlate to the observed
loss of white matter, leading to the concern that the drugs themselves are causing this pathology. The attenuation
of white matter is associated with a loss of myelin, which in the CNS is produced by oligodendrocytes (OLs).
Myelin is necessary for saltatory conduction and trophic support of axons and its loss may contribute to the
clinical changes seen in HAND. Previous work from our lab has demonstrated that select ART drugs prevent the
maturation of oligodendrocytes and myelination, though the mechanisms underlying these observations require
additional investigation. We have further shown that treating maturing OLs with select ART drugs, such as
Elvitegravir (EVG), activates the Integrated Stress Response (ISR), and inhibition of the ISR restores OL
differentiation in the presence of EVG. The ISR is an adaptive pathway used to restore homeostasis in eukaryotic
cells under stressful conditions, and is sometimes characterized by the formation of cytoplasmic stress granules
(SGs), membraneless organelles thought to aid in the global inhibition of translation. Stress granules have not
yet been extensively studied in oligodendrocytes, but research of other neurodegenerative diseases has found
that their presence in neurons may cause acceleration of neurodegeneration. During chronic stress, SGs can
become persistent, and the long-term aggregation of mRNAs and proteins can become pathological. There is
strong evidence associating chronic SG accumulation in neurons with amyotrophic lateral sclerosis (ALS),
Alzheimer’s, and frontotemporal dementia. Our lab has also observed SGs in post-mortem white matter of HIV+
patients with neurocognitive impairment. Furthermore, my preliminary data has shown that maturing OLs treated
with EVG not only activate the ISR, but also form SGs that disappear with ISR inhibition. I hypothesize that during
ARV drug treatment, stress granules sequester mRNAs needed for maturation of OLs via PERK activation of
the ISR, and that these granules form to prevent cell death. I will test this hypothesis via three specific aims. AIM
1: I will determine if ARV Drug induced stress granules in OLs form via the PERK activated ISR. AIM 2: I will
determine the contribution of SG formation to OL survival during ARV drug exposure. AIM 3: I will determine
whether ARV-induced SGs in OLs sequester mRNAs needed for maturation and myelination. Since stress
granules have not previously been characterized in oligodendrocytes, this work will not only provide insight into
improving outcomes of ART treated PWH, but will also benefit research of other neurological diseases
characterized by loss of white matter.

Public health relevance
Project Narrative Despite widespread use of antiretroviral (ARV) therapy, approximately half of people living with HIV exhibit symptoms of HIV-Associated Neurocognitive disorder, a hallmark of which is the atrophy of white matter and the loss of myelin. We have previously demonstrated that select ARV drugs inhibit maturation and differentiation of oligodendrocytes, the cells responsible for myelination in the CNS. The proposed experiments aim to elucidate the role that stress granules play in the inhibition of maturation in ARV treated oligodendrocytes, so as to better understand the mechanisms of oligodendrocyte dysfunction as a prelude to designing therapies.